Administrative Core

Abstract
The Administrative Core of the Cincinnati Cooperative Center of Excellence in Hematology (CCCEH) is
anchored in the Division of Experimental Hematology at Cincinnati Children’s Hospital Medical Center
(CCHMC). The division is built on basic, translational, and clinical interests in the field of non-malignant
hematology, with existing infrastructures and well-integrated scientific and administrative operations. Dr. Yi
Zheng (Director of the CCCEH) is the Director of the Division of Experimental Hematology while Dr. Daniel
Starczynowski (Co-Director of the CCCEH) is a faculty leader in the division and Cancer and Blood Diseases
Institute of CCHMC. As such, the Director and Co-Director of the CCCEH have worked together for a decade,
and will share administrative oversight of the personnel and the complementary research agenda of the center.
The overall goal of the Administrative Core is to ensure that the CCCEH produces a well-coordinated and
highly integrated interdisciplinary research effort on molecular non-malignant hematology, and ensures that the
research cores exert significant impact on the center members’ and extended users’ research activities. These
goals will be accomplished by careful attention to management and scientific communications, through
organization of seminars, advisory committees and retreat meetings by onsite and remote means, by offering
accurate budgetary/accounting, statistical and IT support for the center members, and by providing
administrative/clerical assistance including animal and human subject protocol compliance for all research
cores, core users and center members. Specific Aims of the Administrative Core include: Aim 1. Provide
strong and integrated leadership to set the agenda for the center membership and scientific core management,
and to organize the External Advisory Committee and Internal Advisory Committee. Aim 2. Provide
administrative and clerical support services including financial/budgeting supervision, secretarial support,
animal and human subject protocol development and preparation of reports. Aim 3. Provide information
technology and statistical support to manage the center website and enhance communication and analysis of
data, ideas, and reports among center members and the outreach to the hematology community at large by
social media/remote capabilities. Aim 4. Coordinate the Enrichment Program with the Enrichment Program
Director, including semi-monthly seminars and an annual center retreat, and promote scientific exchanges
through seminars, journal clubs, datablitz, and grant talks within the center and to the national research
community. Aim 5. Facilitate and encourage new hematological projects and training activities by center
member and non-members, particularly emphasizing new investigator/trainee activities and new projects and
moving into translational research with therapeutic opportunities. Backed by strong institutional support, the
Administrative Core serves as the platform for synergy across the scientific cores, and enables center
members, within CHMC and around US, in the hematology field to attain optimal research activity and success.